The impact of adverse interpersonal experiences (AIE) on mild cognitive impairment (MCI) and risk for Alzheimer's disease and related dementias (ADRD) in ethnically diverse twins

ABSTRACT
Age-related decline in cognitive health is a pressing public health concern. Variation in late-life
adult cognitive health is associated with adverse interpersonal experiences (AIEs, e.g.,
loneliness), although documenting the full extent of this association requires further study of a
greater diversity of AIEs. Social isolation and lower quality relationships, characterized by
greater conflict, tend to disrupt psychosocial and biological functioning, resulting in increased
risk for Mild Cognitive Impairment (MCI), which, in turn, increases risk for Alzheimer’s Disease
and Related Dementias (ADRD). Conversely, adults who receive more warmth, support, and
responsiveness in their social experiences typically have better cognitive outcomes. This project
takes advantage of an unparalleled opportunity to further this important line of work on the
significance of relationship experiences in later adulthood for MCI by conducting a follow-up of
the Minnesota-Carolina Twin Study of Aging (MCTSA). MCTSA is a longitudinal study targeting
800 ethnically diverse monozygotic and dizygotic same-sex twin pairs. Most twin participants
have already completed assessments of AIEs in the previous project period. In this proposed
continuation period, we will complete novel assessments of MCI. Further, a daily diary study
aimed at connecting AIEs and fluctuations in cognitive functioning on a day-to-day timescale will
allow us to document processes that presage the development of Alzheimer’s Disease and
Related Dementias (ADRD). Our overarching objectives are to investigate the degree to which
diverse AIEs predict subsequent MCI, to take advantage of the twin aspect of our design to
document the environmental basis for AIE-MCI associations, and to understand how these
connections are manifest in the day-to-day flow of interpersonal experiences and cognitive
functioning. Specific aims of this project include: AIM 1: Document longitudinal associations
between a comprehensive array of earlier, specific adverse interpersonal experiences (AIE) and
subsequent mild cognitive impairment (MCI); AIM 2: Model environmental pathways linking
earlier adverse interpersonal experiences (AIE) and subsequent MCI; AIM 3: Complete a twin
daily diary study of within-person dynamics connecting adverse interpersonal experiences and
daily fluctuations in cognitive functioning.

Public health relevance
NARRATIVE Older adults who encounter adverse interpersonal experiences (AIEs) in their social environment, such as loneliness, typically have higher risk for Mild Cognitive Impairment (MCI) and Alzheimer’s Disease and Related Dementias (ADRD). This project examines the significance of AIEs for diminished cognitive functioning in later life by conducting a follow-up of the Minnesota-Carolina Twin Study of Aging (MCTSA), a longitudinal study of 800 pairs of ethnically diverse twins. The twin design of the study allows a strong test of the hypothesis that AIEs are linked to diminished cognitive functioning and Mild Cognitive Impairment (MCI) with downstream implications for Alzheimer’s Disease and Related Dementias (ADRD) risk through environmental pathways.